COVID-19 Vaccine Uptake and Risk Mitigation Behaviors: Understanding the Role of Institutional Trust

Project Summary
The COVID-19 pandemic has unfolded against the backdrop of diminished public trust in key social and public
health institutions. This erosion of trust is problematic because it undermines individual adherence to key
public health recommendations (e.g., vaccination, mask wearing, physical distancing) which are critical to
managing the COVID-19 crisis as well as future pandemics. While an emerging sub-stream of literature has
begun to unpack the relationship between trust and risk-averting behavior, very little is known about the causal
relationship between trust in larger social institutions (e.g., public health agencies, government, the health care
agencies and the broader health care system) and individual health behavior for the U.S. The goal of this
project is to leverage longitudinal data collected over the course of the COVID-19 pandemic to provide the
most robust assessment to date of the relationship between trust and individual adherence to key public health
recommendations across space and time. The rationale for this project is that trust is a key determinant of not
only effective COVID-19 mitigation but also the mitigation of future disease outbreaks. The objective of this
project will be accomplished by three specific aims: (1) Estimate the impact of individual-level trust in social
institutions on their vaccine intentions and vaccine uptake. (2) Estimate the impact of individual-level trust in
social institutions on their adherence to public health recommendations or non-pharmaceutical interventions
(NPIs), including mask wearing, physical distancing, and shelter-in-place orders. (3) Assess how disparities in
trust, spatially and across sub-populations (race/ethnicity, educational attainment and socio-economic status,
political preference), map onto disparities in compliance with public health guidelines and risk-mitigating efforts.
This project is innovative because it (a) leverages a unique longitudinal dataset to provide some of the first
causal effects on the link between trust and a variety of risk mitigating behaviors (e.g., vaccination, mask
wearing, physical distancing) and (b) utilizes a quasi-experimental design to both quantitatively and
qualitatively assess variation in trust across time as opposed to merely relying on static indicators of trust and
other key variables. The proposed project is significant because it will (a) uncover the relationship between
trust and risk mitigation behaviors, a critical determinant of individual adherence with public health
recommendations, (b) help identify pathways for improving public trust in key social and public health
institutions, in turn helping policymakers and public health officials to better prepare for future COVID-19 waves
and pandemic, and (c) inform the development of recommendations for mitigating the trust-gap between racial,
ethnic, and socioeconomic groups.

Public health relevance
Project Narrative The COVID-19 pandemic has unfolded against a backdrop of diminished public trust in key social institutions at many levels. Eroding trust and confidence in public authorities can have critical implications for public health, especially over the course of a pandemic wherein mounting an effective public health response necessitates a large degree of population buy-in. Given the importance of voluntary compliance with public health guidelines during times of crises, understanding the link between trust and health behaviors is critical towards identifying strategies and modes of public health messaging to maximize public compliance, and for understanding how disparities in trust across socio-demographic groups could drive disparities in risk-mitigation behaviors (and by corollary, COVID-19-related health outcomes).